Core 04: Pilot Projects Program

Project Summary: Pilot Projects Program Core
The goal of the Pilot Projects Program (PPP) Core is to increase the number of junior investigators trained in
clinical and translational research that work with well-established teams of senior scientists developing innovative
research programs to address the chronic disease burden in Louisiana. This is of particular significance to our
region given the major health disparities. To achieve this goal, the PPP Core provides direct and significant
financial support for pilot projects, enables these projects to utilize the expertise and resources of other cores,
facilitates in-kind support across collaborating institutions, and fosters education and training that enhances each
awardee's long-term success as an independent translational investigator. While the current funding cycle was
challenging because of COVID, the PPP funded 36 pilot projects across institutions, including 3 multi-
institutional, multi-investigator “team science” projects, and prior to COVID, 13 Visiting Scholar and Grant
Development awards. These initiatives helped build a collaborative spirit among investigators and resulted in
253 peer reviewed manuscripts by LA CaTS Pilot Project awardees, 117 presentations, and 78 grants awarded
totaling $69.6 million in the first four years of the current funding cycle. Further, 11 pilot project awardees were
academically promoted at their home institution. During the next 5-year cycle we will build on these successes
and expand the number of supported junior investigators where we will prioritize underrepresented minority
investigators and identify “shovel-ready” highly competitive interinstitutional programs that can rapidly compete
for major federal grant initiatives. We will also continue to look towards the future by prioritizing early-stage
investigators and clinicians who can import novel concepts and research techniques to research centers in the
Gulf South. To achieve these goals, we will implement three specific aims. In the first we will solicit, review, and
recommend funding for LA CaTS Pilot Project grant awards that are expected to lead to high quality clinical and
translational research applications for extramural funding. We will prioritize early-stage investigators and junior
faculty from underrepresented minority populations. Second, we will build inter-institutional teams of investigators
that are poised to rapidly compete for major federal grant initiatives addressing existing and emerging diseases
affecting our population and worsening health disparities in the Gulf South. Third, we will provide opportunities
for early-stage investigators and clinicians to engage in new research training opportunities and learn novel,
cutting edge methods to conduct, translate and implement innovative research including clinical trials. At the
conclusion of the next 5-year cycle we expect to have increased the number of funded young investigators,
including underrepresented minority investigators who can support large multi-institutional research programs
and centers of excellence and ensure that we can address health care needs and health disparities in our region
using cutting edge scientific approaches.